Oral Microbial and Immunological Characterization of Patients with Immune Dysfun

The initial focus of our studies has been patient populations with severe neutrophil defects. Patients with severe neutropenia or defective neutrophil recruitment into tissues are known to develop severe-aggressive periodontitis at a young age. However, the mechanisms by which tissue neutrophils alter microbial colonization and regulation of mucosal immunity had not been investigated until recently. One such rare patient cohort is that of Leukocyte Deficiency I (LAD-I). LAD-I is an autosomal recessive immunodeficiency caused by mutations in the CD18-encoding ITGB2 gene that result in defective neutrophil adhesion and transmigration. Affected individuals display neutrophilia, suffer from recurrent infections, and invariably develop early-onset generalized aggressive periodontitis featuring severe bone loss and premature loss of primary and permanent teeth. LAD periodontitis historically has been attributed to the lack of neutrophil surveillance leading to periodontal infection. We recently showed for the first time that IL-17 plays a major role in the oral pathology of LAD-I. Defective neutrophil recruitment in LAD-I patients, or in LFA-1 (CD11a/CD18)-deficient mice that have the same periodontal phenotype, was associated with excessive production of T cell-derived IL-17 in the periodontal tissue. Strikingly, local treatment with anti-IL-17 (or anti-IL-23) in LFA-1deficient mice blocked this inflammatory periodontal bone loss. This novel role for IL-17 in the etiology of LAD-I periodontitis has directed my attention to the development of IL-17targeted therapies for severe periodontal disease.